Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core is responsible for managing and overseeing the SPORE, disseminating information
within the SPORE, and interacting with external agencies, advisors, and related personnel. This Core is led by
Dr. Ie-Ming Shih (Contact PI) from JHU and Dr. Ronny Drapkin (SPORE mPI) from UPENN, who have had
extensive experience in research administration, fiscal management skills and leadership in multi-institutional
research projects. The Administrative Core serves the entire SPORE Program in several key areas of
coordination and oversight. It will interact with the Biorepository/Pathology Core and the Biostatistics Core, as
well as with investigators from each research project. The Core leaders are responsible for planning, managing
and directing the overall operations of the program. They will ensure the attainment of strategic objectives and
the delivery of quality administrative support to all research projects, programs (CEP and DRP) and other
Cores, as well as promote resource sharing, new research opportunities, and patient advocacy. This Core will
also coordinate essential program interactions, including all planning and evaluation activities, arranging and
publicizing SPORE activities, monitoring data and safety, coordinating advisory committee meetings,
summarizing annual reports, and performing analysis of budgetary matters. Overall, through the functions
mentioned in the following description, the Administration Core will provide an essential service to each of the
Research Projects and Core Resources to facilitate the accomplishment of the proposed goals and objectives
of the SPORE as a whole, to effectively communicate with other entities, and to disseminate exciting findings
to stakeholders.

Public health relevance
ADMINISTRATIVE CORE: NARRATIVE We propose this SPORE to study translational ovarian cancer research, and the Administrative Core provides coordination and facilitation of efforts to collectively bring new molecular diagnostics and novel therapeutic approaches to women with this devastating disease.